MoTrPAC DXA Quality Control

MoTrPAC DXA Supplement - Project Summary
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) is designed to discover and
characterize the range of molecular transducers underlying the effects of exercise in humans. MoTrPAC was
launched in 2016 with six adult clinical centers and a pediatric center that have collaborated to generate
extensive Manual of Operations to guide research protocols involving all aspects of the clinical operations
(Phase I). Phase II began in the fall of 2019 with all human clinical centers showing excellent progress towards
initial recruitment goals and implementation of the protocol. The initial goal set forth by NIH was to recruit 270
children (10-17 years of age) and 1980 sedentary adults (age 18 years or greater) randomized to endurance
training (170 youth, 840 adults), resistance training (840 adults), or non-exercise controls (50 youth, 300
adults). An additional group of highly active endurance (50 youth, 150 adults) and resistance (150 adults)
trained individuals serve as comparators, not participating in the MoTrPAC exercise training programs. The
recruitment and enrollment approach are sex-balanced, with participants across a wide range of ages (10-17,
18-39, 40-59 and >60-year age groups) and of different races. Due to the COVID-19 pandemic, beginning in
March 2020, MoTrPAC activities were suspended for over a year with continued constraints through 2022.
Despite the numerous challenges encountered as a result of the pandemic, the human clinical centers have
successfully enrolled and completed the adult and pediatric highly active cohorts, the pediatric cross-sectional
cohort, and the previously sedentary adult and low-active pediatric randomized control trial portion of the study
as of May 2025. As data quality control is underway, discrepancies in dual-energy X-ray absorptiometry (DXA)
data have been detected across different machines. This led NIAMS to provide MoTrPAC with funding to
conduct additional DXA scans among previously enrolled MoTrPAC participants to develop a correction
equation accounting for differences in DXA machines, allowing all MoTrPAC DXA data to be included in the
final dataset. Altogether, this will allow MoTrPAC to complete the intended goals as originally envisioned, will
provide a more complete public database of the health benefits of exercise, and will provide insight into how
physical activity mitigates disease risk.

Public health relevance
MoTrPAC Narrative While there are many important health benefits of physical activity, how exercise exerts its effects is not fully understood. A more comprehensive understanding of the molecular mechanisms underlying the responses to exercise would significantly impact public health. Developing a correction equation for Molecular Transducers of Physical Activity Consortium (MoTrPAC) dual-energy X-ray absorptiometry (DXA) data will allow the consortium to achieve its objective of generating a comprehensive map of the molecular responses to acute exercise and exercise training with the long-range goal of elucidating the mechanisms by which exercise improves health.